Interplay of Inflammation, Angiogenesis, and Coronary Microvascular Perfusion in Advanced Kidney Disease

PROJECT SUMMARY/ABSTRACT
Chronic kidney disease (CKD) is associated with accelerated cardiovascular (CV) aging including maladaptive
myocardial and vascular remodeling, ultimately increasing cardiovascular risk independent of traditional risk
factors. Microcirculatory dysfunction plays a key role in the early stages of myocardial injury and dysfunction.
Specifically, a decline in myocardial flow reserve (MFR) - a well-validated quantitative marker of vascular
health assessed using positron emission tomography (PET) – is linked to maladaptive myocardial remodeling
and adverse outcomes. Chronic systemic and vascular inflammation, which is highly prevalent in CKD, is
linked to endothelial dysfunction, dysregulated angiogenesis, atherosclerosis, myocardial dysfunction, and
abnormalities in the coronary microcirculation. Kidney transplantation offers a unique observational model to
examine the impact of reducing CKD-related inflammation on CV outcomes, including coronary microvascular
function and myocardial mechanics. The goal of the proposal, based on the observational study RESTORE
(Impact of Renal Transplant on Coronary Microvascular Function in Patients with Advanced Chronic Kidney
Disease), is to mechanistically explore cardiovascular health before and after transplant, focusing on the
interplay between inflammation, angiogenesis, myocardial perfusion and myocardial function. We hypothesize
that systemic inflammation and dysregulated angiogenesis contribute to abnormal myocardial blood flow,
measured by PET, and abnormal myocardial mechanics, assessed by echocardiography, in patients with
advanced CKD on the transplant waitlist (Specific Aim 1). Leveraging transplantation as an observational
intervention, we further hypothesize that kidney transplant will be associated with improved myocardial blood
flow and myocardial mechanics (Specific Aim 2), and that reductions in inflammation and dysregulated
angiogenesis after transplant will be associated with improved myocardial blood flow and function (Specific
Aim 3). By gaining a mechanistic understanding of how CKD, its associated inflammation and dysregulated
angiogenesis, and kidney transplant influence myocardial blood flow and function, this study may lead to
targeted preventive therapies in the future, such as immunomodulatory treatments, including IL-6 inhibitors.
The proposal will be accomplished within a comprehensive career development plan designed to provide the
award applicant Dr. Huck, who is a cardiovascular imaging specialist and early career investigator, the skills to
become an independent R01-funded clinical-translational investigator and academic leader performing
mechanistic and therapeutic clinical trials with imaging endpoints in people with kidney disease. Dr. Huck has
an expert mentorship team of multidisciplinary researchers in coronary microvascular dysfunction, kidney
transplant, clinical trials and state-of-the-art cardiovascular imaging and a superb environment for early career
development at Brigham and Women’s Hospital and Harvard Medical School. He is ideally supported for a
transition to scientific independence over the course of the award period.

Public health relevance
PROJECT NARRATIVE Inflammation, dysregulated angiogenesis, and resultant coronary microcirculatory dysfunction in individuals with advanced chronic kidney disease (CKD) may play a significant, yet under-recognized, role in driving maladaptive vascular and myocardial aging, as well as increasing cardiovascular risk; targeting these early indicators of subclinical cardiovascular disease could potentially improve outcomes. Kidney transplant provides a unique observational opportunity to study the effects of reducing CKD-related inflammation on cardiovascular health, including myocardial blood flow as measured by PET imaging (a well-established, quantifiable marker of coronary microvascular function) and myocardial mechanics assessed by echocardiography. The goal of the proposed study is to explore the mechanisms linking cardiovascular health and advanced CKD, testing the hypothesis that reduction in inflammation and dysregulated angiogenesis after transplant will be associated with improved myocardial blood flow, and thereby improved myocardial tissue perfusion, left ventricular mechanical function, and ultimately symptoms and functional capacity.